Deciphering the mechanisms of nucleolar stress response during MCPyV infection

PROJECT SUMMARY
Merkel Cell Polyomavirus (MCPyV) is a double-stranded DNA human tumor virus that is the main causative
agent of Merkel Cell Carcinoma (MCC), a rare, but extremely aggressive skin cancer. MCC predominantly affects
elderly or immunosuppressed patients. Currently, there is a lack of durable and effective treatment options to
treat this cancer, thereby necessitating the need to identify new therapeutic options as rates of MCC are steadily
increasing. Before the onset of MCC, MCPyV establishes a latent infection and therefore, must have its own
mechanisms to promote long term survival within its host to cause MCC later in life. It is known that other human
tumor viruses, such as Human Papilloma Virus (HPV), induce cell cycle arrest in infected cells to promote viral
persistence. My previous results showed that MCPyV induces host cell cycle arrest and cellular senescence by
expressing the large tumor antigen (LT) as a mechanism to promote viral genome maintenance in human
fibroblast cells. When investigating how MCPyV LT might induce cellular senescence, we observed that this viral
oncoprotein induces the nucleolar stress response (NSR), a host stress response that functions to cause cell
cycle arrest and/or cellular senescence, usually in a p53-dependent manner. The NSR is canonically activated
upon factors that can inhibit ribosomal biogenesis and often results in disruption of the nucleolar structure and
activation of p53. Though this stress response has been characterized in response to nutrient starvation,
chemotherapeutic drugs, or other stressors, it has not been sufficiently defined in the context of viral infections.
The goal of this proposal is to determine how the NSR is regulated by MCPyV infection and how this stress
response might impact MCPyV replication. Specifically, my preliminary data indicated that MCPyV LT
downregulates processes that regulate ribosomal RNA (rRNA) expression and processing, or dysregulates
ribosomal assembly and/or protein synthesis seen by a lack of phospho-ribosomal protein S6 (p-RPS6)
expression, implicating a potential role of LT in modulating ribosomal biogenesis on the RNA and protein level.
Accordingly, the central hypothesis of this proposal is that MCPyV LT can inhibit ribosomal biogenesis to
induce the NSR, which is required for MCPyV viral persistence. To address this hypothesis, Specific Aim
1 will characterize the NSR phenotypes and elucidate the mechanism and processes of ribosomal biogenesis
that are directly disrupted by MCPyV LT. Specific Aim 2 will investigate the mechanism by which MCPyV LT
promotes p53 activation and how the p53-dependent NSR regulates MCPyV genome replication and
persistence. Taken altogether, the findings from this proposal will significantly expand our understanding on the
role of the NSR as a critical viral sensor and identify host factors that are essential for MCPyV pathogenesis.

Public health relevance
PROJECT NARRATIVE The nucleolar stress response (NSR) functions to maintain cellular homeostasis when the cell is faced with stress or suboptimal growth conditions. This research proposal will investigate how this stress response is regulated by and how it might impact viral replication of Merkel Cell Polyomavirus, a human tumor virus that causes a highly fatal skin cancer called Merkel Cell Carcinoma (MCC). Such work will advance our understanding of the role of the NSR during viral infections, an area which has not been well described, and identify potential therapeutic targets to prevent the onset of MCC.